Machine learning-enabled design of prototype pathogen vaccines and antibodies

PROJECT SUMMARY – OVERALL: MACHINE LEARNING-ENABLED DESIGN OF PROTOTYPE
PATHOGEN VACCINES AND ANTIBODIES
We propose a highly synergistic Center focused on developing end-to-end strategies for pandemic
preparedness vaccine development for bunyaviruses and paramyxoviruses. Our Center brings together five
research institutions with complementary and synergistic expertise in computational protein design,
structure-based vaccine design, mRNA vaccines, structural biology, viral entry, viral diversity and evolution,
animal model development, high biosafety-level containment virology, vaccinology, and vaccine process
development and technology transfer. Our team has real-world experience in vaccine and biologics product
development in both academic and industry settings. Our Center comprises five Scientific Projects supported
by three Scientific Cores, an Administrative Core, and a Data Management Core. Our Scientific Projects
include: 1) Development of computational methods for vaccine and biologics design, 2) Fundamental research
on viral entry and receptors, 3) Antigen design, 4) Protein nanoparticle vaccine development, and 5) mRNA
vaccine development. We will structure our efforts in two phases: in Phase 1 (Years 1-3) we will focus on
developing vaccines for our prototype pathogens and in Phase 2 (Years 4-5) we will apply those learnings to
two new bunyaviruses and two new paramyxoviruses to demonstrate that our computational and experimental
approaches generalize across viral families. Our prototype pathogens are: Lassa virus (LASV; arenaviruses),
Rift Valley fever virus (RVFV; phenuiviruses), and Hendra virus (HeV; paramyxoviruses). We carefully selected
our prototypes as we believe they present specific vaccine design challenges which, if we are successful in
solving, will facilitate the development of vaccines against related viruses. Simultaneously, the antigens from
viruses in these three families have some similarities that will give rise to synergies in our design approaches.
The structure of our Center will allow maximal synergy between our groups in pursuit of its central output: to
define generalizable approaches and tools to develop vaccines and biologics for emerging pathogens with
pandemic potential.

Public health relevance
We propose a highly coordinated and synergistic Center that will develop end-to-end approaches and generalizable methods for designing potently protective vaccines against paramyxoviruses and bunyaviruses. Our Center brings together groups with world-leading expertise in computational protein design, structure-based vaccine design, mRNA vaccines, structural biology, viral entry, viral diversity and evolution, animal model development, high biosafety-level containment virology, vaccinology, and vaccine process development and technology transfer. Our Center will generate new knowledge, tools, and generalizable vaccine design approaches that will significantly advance vaccine development for pandemic preparedness generally, and will have a direct impact on public health through the development of antibody and vaccine candidates for several paramyxoviruses and bunyaviruses.